ANTIFOLATE THERAPY OF AUTOIMMUNE DISEASES

The purpose of this trial is to determine the optimal dose of supplemental folic acid to be used during methotrexate therapy for rheumatoid arthritis, to lessen toxicity, and maintain efficacy.